Mechanomolecular regulation of cell division

PROJECT SUMMARY
Cell division is a physical process when the genome - distributed across the replicated chromosomes - is equally
separated prior to cleavage into two daughter cells. Given its central importance to life, integrated physical and
biochemical fail-safe mechanisms have evolved to make cell division a high-fidelity process. However, natural
selection does not yield perfection and failures in cell division result in aneuploidy, which causes a majority of
miscarriages in the first trimester, birth defects, and has been implicated in tumorigenesis and cancer metastasis.
Our long-term goal is to characterize fundamental and conserved mechano-molecular mechanisms of cell divi-
sion. In the proposed work, we will combine advanced live-cell imaging approaches with molecular and biochem-
ical methods to advance two areas of inquiry central to successful cell division. First, we will investigate the
functional contributions of extremely large intrinsically disordered regions (ELIDRs) in proteins at the kinetochore
and perichromosomal layer. Second, we will study how a phenomenon called branching microtubule nucleation
is regulated to promote efficient and timely capture of chromosomes by spindle microtubules. A more compre-
hensive understanding of how the complex biological processes of cell division are orchestrated by mechanical
and biochemical pathways will be foundational to treating diseases stemming from improper cell division.

Public health relevance
PROJECT NARRATIVE Cellular mechanisms that ensure faithful transmission of the genome during cell division are vital to normal embryonic development and the maintenance of healthy tissues through adulthood. Mistakes during cell division lead to cells acquiring an abnormal number of chromosomes – a pathological cellular state called aneuploidy. The proposed research will provide opportunities for improving disease treatment and prevention by characterizing fundamental cell division processes.